CHEMICAL TRANSMISSION AT THE SQUID GIANT SYNAPSE

The model of exocytosis based on the existence of ion channels in the secretory vesicle membrane, that we proposed, was tested at the giant synapse of the squid. The ion-channel-blocking agent nonyl-triethylammonium (9-TEA) was injected directly into the presynaptic nerve terminal in an attempt to inhibit exocytosis. Transmitter release was blocked by 9-TEA but this effect was attributed to a blocking action on calcium channels, invalidating this approach with this compound. Further attempts at this experimental strategy will have to await more specific blocking agents.